Deciphering genetics of PLCG2 alternative splicing to understand AD risk

The majority of Alzheimer’s disease (AD) risk is genetic and genome wide association studies (GWAS)
have identified 75 AD-associated SNPs. In other fields, pharmacologic agents targeting proteins identified
through genetics have produced striking success. However, the AD field has lagged, partly because we have
struggled to identify the molecular mechanisms whereby genetic variants impact AD. This proposal focuses on
the phospholipase PLCG2, which was initially associated with AD through a missense SNP, rs72824905
(P522R), that strikingly reduces AD risk. PLCG2 modulates microglial function by mediating signaling from
TREM2 and related receptors. P522R appears a hypermorphic mutation that increases PLCG2 function
through an unclear mechanism. However, homozygosity for P522R is apparently deleterious, suggesting that
PLCG2 activity must be tightly controlled for optimal brain aging. In considering PLCG2 genetics and AD, we
recognized that PLCG2 expression and splicing relative to AD genetics have not been scrutinized. Indeed, a
SNP upstream of PLCG2, rs12446759, was recently associated with AD risk in a GWAS; the actions of this
GWAS SNP are not clear although eQTL compendia suggest that this SNP is associated with expression of
the lncRNA RP11-960L18, some isoforms of which include PLCG2 beginning at exon 2. To address the gap
in our knowledge regarding PLCG2 expression and AD genetics, we propose to elucidate the extent that
genetics modulate PLCG2 expression and splicing, to identify the underlying mechanisms, and to identify
proof-of-concept approaches to improve PLCG2 expression to reduce AD risk. In preliminary work, we
identified a novel PLCG2 splice variant, D65-PLCG2, in human brain, quantified this isoform in AD and non-AD
brain samples, and identified a SNP, rs1071644, within the variant exon that correlates with expression of this
novel isoform. Remarkably, rs1071644 is associated with increased AD risk (p=9x10-8). Rs1071644 appears
to be a novel AD risk factor because this SNP is not co-inherited with either the GWAS SNP, rs12446759 or
P522R according to LDpair. In summary, our global hypothesis is that genetic variants impact PLCG2 splicing
and/or expression to alter PLCG2 function and thereby modulate AD risk. To explore this hypothesis, we
propose these Specific Aims: 1: Identify and quantify PLCG2 isoforms expressed in human brain as a
function of AD neuropathology and genetics. 2: Compare PLCG2 and D65-PLCG2 protein expression
and function. 3: Translate PLCG2 splicing genetics to identify modulators predicted to reduce AD risk.
Successful completion of these studies will reveal rs1071644 as a novel AD risk factor that acts via PLCG2
splicing, show that the AD GWAS SNP rs12446759 alters expression of a novel RP11-960L18_PLCG2
isoform, test whether the D65-PLCG2 represents a gain or loss of function, and begin to translate these
findings to pharmacologic modulation. By defining the extent that genetics regulate PLCG2 expression to alter
AD risk, these results will inform drug development targeting this pathway.

Public health relevance
We have identified a novel PLCG2 splice variant that is increased in human brain by a polymorphism that is associated with the risk of Alzheimer’s disease. In this proposal, we will confirm these preliminary findings, test whether the PLCG2 isoform generates a stable and functional PLCG2 protein, and identify splicing modulators that improve PLCG2 splicing to reduce AD risk. Overall, this proposal will provide quantitative insights into PLCG2 expression relative to AD risk, test the role of splicing in PLCG2, and begin to translate our findings into a potential pharmacologic approach.